Yale Core Grant for Vision Research

Yale Core Grant for Vision Research
Project Summary
The overall objective of the Yale Vision Research Core Program is to provide fundamental and innovative
technologies to support and enhance vision research at Yale University. With three key resource/service
Core modules, this Program will aid the ongoing research projects of vision investigators by providing
facilities and expertise that cannot be readily supported by individual research grants. The Core grant will
facilitate a collaborative environment that increases the scientific interactions between vision researchers
and extends interactions to researchers in other fields. The Core grant will facilitate the development of
vision research programs for new investigators at Yale and for established investigators interested in
entering the field of vision research.
Three Core modules are proposed to maximize impact on vision research at Yale. A Neurotechnology &
Fabrication Core will assist in the design, development and construction of a wide range of custom
experimental apparatus for vision research (e.g., microscopes, recording chambers, behavioral rigs). These
custom technologies will be used in studies that employ a range of model systems (e.g., fly, fish, mouse,
non-human primate, human, cell culture) and levels of analysis (e.g., single cell recording, functional
imaging, behavior). This module also supports the development of computer-machine interfaces and minor
programming applications. A Virus Production & Molecular Biology Core will produce high quality, high-titer
adeno-associated virus (AAV) as well as custom design of DNA constructs for a wide range of applications
at multiple levels of the visual system (e.g., retina, thalamus, superior colliculus, visual cortex). This module
will also offer consulting services for basic molecular biology and histology techniques, including genotyping
and immunostaining. An Imaging Core will provide physical facilities and intellectual resources for state-of-
the-art static and dynamic imaging of cells and tissues of the visual system. This module will provide
practical and didactic training on microscopes to maintain a high level of proficiency and expertise among
vision researchers. These three Core modules comprise a comprehensive Core Program that serves the
fundamental needs of vision researchers at Yale University.

Public health relevance
Yale Core Grant for Vision Research Project Narrative The overall objective of the Yale Vision Research Core Program is to provide fundamental and innovative technologies to support and enhance vision research at Yale University. With three key resource/service Core modules, this Program will aid the ongoing research projects of vision research investigators by providing facilities and expertise that cannot be readily supported by individual research grants. This Core Program will enhance scientific interactions between current and future vision researchers at Yale and will facilitate the development of vision research programs for new investigators and for established investigators interested in entering the field of vision research.